Project 3 – Stromal derived IL-6/STAT3 signaling in the development and progression of PDAC

PROJECT SUMMARY: PROJECT 3
PDAC is among the most deadly malignant solid tumors, with approximately 92% of patients succumbing to the
disease within five years of diagnosis, and with no effective therapies beyond surgery. Importantly, it is widely
recognized that patients with PDAC are especially prone to cachexia, a syndrome characterized by pronounced
weight loss due to depleting skeletal muscle and adipose tissues. As a result, patients are often weak and
fatigued, which makes them less tolerant to chemo- and radiotherapy. The histopathological hallmark of PDAC
is its uniquely dense stromal reaction, comprised of activated, cancer associated fibroblasts, increased extra-
cellular matrix (ECM), immune cell infiltrates, and abnormal angiogenesis. This has engendered attention for
selectively targeting the tumor stroma to increase therapeutic efficacy. However, stromal cancer-associated
fibroblasts can also have tumor suppressive functions, challenging the efficacy of stromal-targeting therapies. In
addition, there is increasing appreciation for the dual role of stromal mesenchymal cells in muscle homeostasis
and regeneration, as well as in muscle wasting diseases, including cancer cachexia. Progress in tackling PDAC
will require new knowledge of its macroenvironment encompassing crosstalk between the tumor and peripheral
tissues. In Project 3, we posit the IL6/STAT3 pathway is a key pathway involved in PDAC macroenvironment
cross-talk. Synergistic interactions with the Projects and Cores in this Program Project will allow us to test the
hypothesis that STAT3 signaling in stromal mesenchymal cells present in the tumor and muscle is a component
of a feed-forward loop in the tumor macroenvironment that favors PDAC progression and cancer cachexia.

Public health relevance
PROJECT NARRATIVE: PROJECT 3 Pancreatic ductal adenocarcinoma (PDAC) is a malignancy with staggering statistic, with ~8% of patients surviving five years after their initial diagnosis, and PDAC patients are especially prone to cachexia, a syndrome characterized by pronounced weight loss due to depleting skeletal muscle and adipose tissues that contributes to mortality in this disease. One hallmark of PDAC is the dense stroma consisting of activated cancer fibroblasts that surround each tumor, however, the role of these l cells in supporting tumor growth and cancer cachexia is controversial, and major gaps in knowledge exist regarding their contribution to cancer progression and cachexia. In this project, we propose to determine the function of the IL6/STAT3 signaling pathway, a pathway that could be targeted with existing drugs, in the communication between the stroma in the tumor and in peripheral tissues affected in cachexia.